SEARCH for Diabetes in Youth 2: Ohio Center

[unreadable] DESCRIPTION (provided by applicant): This proposal builds upon a five year research project, SEARCH for Diabetes in Youth, its standardized data collection effort, experienced investigator team, established case ascertainment infrastructure, and ethnically diverse population base. This is a common, integrated application from the six SEARCH clinical sites, which proposes to continue and expand the work performed by SEARCH in order to address the following specific research aims: AIM 1: Prospectively ascertain newly diagnosed (2006-2009) incident cases age less than 20 years in order to estimate temporal trends in incidence of DM in youth: AIM 2: Conduct longitudinal follow-up of incident cases already recruited to SEARCH in 2002-2005 in order to document the evolution of newly diagnosed DM according to clinical and biochemical factors; AIM 3; Complete analyses initiated in the first five years of SEARCH and expand the scope of quality of care assessment to encompass more broadly defined concepts and measures of quality; AIM 4: Develop and validate simple and low-cost case definitions and classifications of DM types in youth that can be used for public surveillance. [unreadable] [unreadable] The novelty of this proposal includes its comprehensive nature that brings together major and timely facets of childhood DM research: and epidemiologic study, unique in the United States, of temporal trends in the incidence of DM in youth; a pathophysiologic component addressing the natural history of DM in youth: a study of processes of care and quality of life; and a public health perspective on case classification of DM in youth. This research is critically important to public health as it will provide information about whether and how much DM is increasing among youth of different racial/ ethnic groups in the United States, about how DM impacts on the physical health, including complications, as well as valuable data regarding the quality of care and the quality of life of these youth. The major strengths of the Ohio site are dominant market position of Cincinnati Children's Hospital Medical Center (CCHMC), CCHMC's commitment to research and diabetes care, the excellent rapport CCHMC has with the surrounding community, and the track record of Ohio SEARCH investigators for successful collaboration. Based on these strengths, the Ohio site used a comprehensive diabetes patient database at CCHMC and built a community network to ascertain 99.8% (estimate by capture-recapture analysis) of the cases of diabetes in youth in the Ohio geographic area in SEARCH1. [unreadable] [unreadable]